The CFTR Interactome

Project Summary
Cystic Fibrosis (CF) is caused by mutation of the CFTR gene and is one of the most common inherited
childhood diseases, impacting 1 in 4,000 children born in the US (www.cff.org). Today, CF disease symptoms
in patients with the most common mutation (∆F508 CFTR) can be improved with three different drug
combinations. However, the drugs have negative side effects that reduce patient compliance to therapeutic
regimens and pose long-term health risks. Additionally, many other common CF-causing mutations respond
poorly or not at all to any of the current CF drugs, leaving CF patients carrying these mutations only with
symptomatic therapy. Efforts to develop new compounds for such CF variants are hampered by the lack of
protein structures that would reveal the conformational defects of these variants, mostly due to technical
difficulties in expressing and purifying sufficient quantities of these unstable proteins. To characterize the
conformational defects of misfolded CFTR variants and to aid in the development of new therapies, we
previously developed Covalent Protein Painting (CPP), a novel method for in vivo structural characterization of
proteins by mass spectrometry. Here, we propose to develop a more sensitive and multiplexable CPP method,
named bioTMT-CPP, that will facilitate detection and comparison of CFTR conformational changes between
samples. The new method will facilitate the characterization of conformational defects in misfolded CFTR
variants that are refractory to current therapies. Furthermore, our approach has the potential to pinpoint drug
binding sites and identify the mechanism of action of current CF drugs, which remain unknown for three of the
four active compounds. Such knowledge will help to rationalize drug combination therapies. We also propose
to functionally characterize a novel CFTR conformation that we discovered by CPP and that is attained by
misfolded and inactive CFTR, likely during protein trafficking. Insight into the molecular mechanisms that
stabilize this conformation as well as those that release it into an active conformation will be invaluable for
further corrector drug development and will benefit all CF patients.

Public health relevance
Project Narrative Cystic Fibrosis (CF) is one of the most common inherited childhood diseases, impacting 1 in 4,000 children born in the US (www.cff.org) and is caused by mutations of the CFTR protein that affect its 3-dimensional structure and function. While therapies now exist to treat the most common CFTR mutation, other common mutations do not respond to any of the drugs, so many CF patients are left without treatments. Through the development and use of new mass spectrometric methods, we aim to characterize the structural defects of CFTR variants that do not respond to current treatments and to understand the mechanisms of action of CF drugs to aid in the identification of new strategies of therapeutic intervention.